Project 3: Therapeutic Targeting of Lineage Plasticity in Castration-Resistant Prostate Cancer

ABSTRACT/SUMMARY
The clinical success of androgen receptor signaling inhibitors such as abiraterone and enzalutamide has
significantly extended survival for men with castration-resistant prostate cancer (CRPC), but metastatic CRPC
tumors inevitably acquire resistance to these agents through a variety of mechanisms. Of particular concern,
due to the increased aggressiveness and lethality, is the development of lineage plasticity: when the tumor
transitions from a classical, androgen receptor (AR)-positive, prostate-specific antigen (PSA)-expressing
adenocarcinoma to an AR-low/negative, PSA-low tumor with undifferentiated or neuroendocrine/small cell
histology. These tumors display considerable heterogeneity in expression of various marker genes, including
AR, luminal cytokeratins such as CK8, and neuroendocrine markers such as synaptophysin or chromogranin.
This heterogeneity is an anticipated consequence of the underlying lineage plasticity of these tumor cells but
leads to confusion in how to precisely define this transition stage, particularly for the purpose of eligibility for
clinical trials. Recent insights from tumor sequencing have identified additional features associated with lineage
plasticity, such as genomic alterations in TP53 and RB1, increased expression of EZH2 and SOX2, and
activation of stem-like RNA signatures, but none of these currently serve as a validated biomarker. In addition
to the diagnostic challenges, this magnitude of heterogeneity raises obvious concerns about the feasibility of
successful therapeutic intervention. Our perspective is that this challenge can be addressed only if we have a
more detailed understanding of the magnitude of heterogeneity and the underlying molecular drivers of that
heterogeneity. Toward that end, we have deployed RNA sequencing and spatial imaging technologies to
characterize intra- and inter-tumoral heterogeneity in CRPC at a single-cell level. Based on our initial leads, we
will be investigating inhibitors of JAK kinases, FGFR, EZH2, and p300/CBP in preclinical models using patient-
derived organoids and xenografts, to understand these agents’ activity against CRPC that has developed
lineage plasticity. Another major goal of this project is to address this diagnostic challenge by evaluating these
markers in blood-based assays such as circulating tumor cells (CTCs) and cell-free tumor DNA (cfDNA) (Aim
3). To that end, we will evaluate the frequency of DLL3 expression and additional CTC/cfDNA biomarkers
representing therapeutic targets in Aim 2, and investigate morphologic, phenotypic and genomic heterogeneity
within biomarker-positive CTC sub-populations. Finally, we will investigate whether persistent CTC
subpopulations can be utilized to provide an early indication of response, identify potential resistance
mechanisms, and guide future therapeutic development. The primary goal of this project will be to leverage our
findings, including focusing on the use of single-cell technology to further characterize this heterogeneity (Aim
1), investigate four drug targets implicated in various stages of lineage plasticity (Aim 2), and develop blood-
based biomarkers of lineage plasticity that can be incorporated into clinical trials (Aim 3).

Public health relevance
PROJECT NARRATIVE Recent genomics studies have shown that men with castration-resistant metastatic prostate cancer harbor an unexpectedly high frequency of alterations in the tumor suppressor genes TP53 and RB. In laboratory studies, we have found that these alterations lead tumor cells to change their identity and thereby become resistant to anticancer therapies that target the androgen receptor. In this project, we will characterize these altered tumor cells through single-cell analysis, evaluate four inhibitory therapies that may delay, prevent, or even reverse the changes that cause resistance, and develop blood-based biomarkers that can be incorporated into clinical trials to predict and monitor patient response to these types of therapies.